Admin & Enrichment Core

The Administrative/Program Enrichment Core is the administrative arm of the San Antonio Nathan Shock Aging Center. Under the direction of Drs. Arlan Richardson and Randy Strong, the Core will be responsible for the management of the Center, the annual reports, and the evaluation of the Center. In addition, the Administrative/Program Enrichment Core will provide Cores and Center investigators with data management and biostatistical support. This Core also will be the organizational unit responsible for promoting research in basic biology of aging in San Antonio. This will be accomplished through seminars, meetings, and conferences that focus on various aspects of aging. The Administrative/Program Enrichment Core also will be the organizational unit that provides investigators outside the UTHSCSA with access to the services and programs provided by the San Antonio Nathan Shock Aging Center. The goal of our Center will be to administer Research Cores that will become regional/national resources for investigators studying aging. In addition, the Administrative/Program Enrichment Core will be responsible for collaborative efforts with other Nathan Shock Aging Centers. The Specific Aims of the Administrative/Program Enrichment Core are as follows: 1. To provide administrative/management support for the Center, 2. To conduct evaluations of the Center, 3. To provide data management and biostatistical support to the Research Cores and Center members, 4. To foster an environment that stimulates collaborative efforts in aging at San Antonio, and 5. To promote interactions in aging research and the sharing of Core resources/services with investigators at other institutions and collaboration with other Nathan Shock Centers.

Public health relevance
The Administrative/Program Enrichment Core organizational unit of the San Antonio Nathan Shock Center that is responsible for the administration of the Center and promoting research in basic biology of aging in San Antonio. The Administrative/Program Enrichment Core also will be responsible for collaborative efforts with other Nathan Shock Aging Centers.